Mechanisms of tunneling nanotube formation by ZIKV NS1 in viral host interactions at the maternal-fetal interface

PROJECT SUMMARY
Although primarily transmitted by mosquitoes, the Zika virus (ZIKV) has the unique ability among flaviviruses to
be transmitted horizontally through sexual contact, or vertically from mother to fetus. The vertical mode of
transmission has led to devastating pregnancy and fetal development outcomes that came to light in 2015-16,
as a ZIKV epidemic emerged in the Western hemisphere and a public health emergency of international concern
was declared. The threat of future ZIKV epidemics persists and many nations where it has become endemic
continue to struggle with the adverse effects of infection. Meanwhile, scientists have struggled to understand the
mechanisms that underlie maternal-fetal transmission of ZIKV on a cellular and molecular level. This proposal
presents preliminary data for the first time that supports a novel hypothesis that transmission of ZIKV at the
maternal-fetal interface is facilitated by the formation of tunneling nanotubes (TNTs), which are actin-based
intercellular transport conduits that have been shown to play a role in the spread of other viruses. Among other
things, the preliminary data indicates that, 1) ZIKV infection induces the formation of TNTs in various cell types,
including human placental trophoblast cells, 2) the ZIKV non-structural protein 1 (NS1) is alone sufficient to
induce TNT formation, whereas NS1 proteins of several other flaviviruses tested do not appear to have this
ability, with the exception of WNV to a small degree, and 3) ZIKV-induced TNTs transport mitochondria in
trophoblast cells in a manner that may be exploited for the benefit of virus propagation and transmission. Building
on these observations, and using the tools the PIs have so far developed, they propose a formal collaboration
and rigorous set of experiments designed to test this hypothesis. First, using a library of labeled ZIKV constructs,
confocal imaging, and an advanced affinity purification-mass spectrometry approach, the role of NS1 in inducing
TNT formation without affecting virus replication and assembly will be established in human trophoblast cells;
then specific regions of this protein will be identified that may participate in signaling or interaction with host
proteins; and the question of whether TNTs transport ZIKV RNA and/or whole virions will be evaluated. Second,
mouse models of ZIKV infection during pregnancy that the PIs have developed in prior work will be used to
investigate the role of TNT formation in ZIKV pathogenesis and vertical transmission; the impact of TNT formation
on ZIKV infection pathogenesis in the placenta will be evaluated; and spatial transcriptomics paired with tissue
profiling will be used to identify genomic pathways in the placenta that are key for TNT formation. And thirdly,
the nature of mitochondria transport via TNTs will be investigated to determine the role of any interactions with
ZIKV virions or NS1, and the effects this has on cell metabolism and viral transmission. If successful, the resulting
findings will establish an important and undescribed cellular pathway for transmission of the ZIKV that will serve
as a likely target for future therapeutic interventions aimed at preventing microcephaly and other effects of ZIKV
infection during pregnancy.

Public health relevance
PROJECT NARRATIVE Zika virus infections during pregnancy are linked to fetal mortality and morbidities often characterized by microcephaly and other congenital Zika syndrome developmental disorders, and this characteristic appears to be highly unique to Zika virus among flaviviruses. Here, we present preliminary evidence showing that spread of this virus at the maternal-fetal interface is linked to intercellular conduits known as tunneling nanotubes, which we show are induced in the placenta during ZIKV infection. We propose to investigate the relationship between the Zika virus and tunneling nanotubes in both cell and mouse models to establish a previously undescribed and important cellular mechanism for the vertical transmission of the virus that can be targeted for therapies that intervene with congenital Zika syndrome.